Advanced Development of Patient Ascites Therapeutic Response Biosensors

PROJECT SUMMARY/ABSTRACT: Overcoming cancer drug resistance is a major unmet clinical need across
many cancer types, including difficult-to-treat diseases such as gastroesophageal (GEA) and ovarian cancer. In
principle, it should be possible to prioritize therapeutic regimen(s) given the molecular and cellular classification
of such tumors. However, two bottlenecks prevent sustained progress. First, biopsies from refractory disease
are challenging to routinely obtain and evaluate, especially in community settings, both for clinical and
research purposes. Second, even when such material is procured, it remains challenging to accurately predict
therapeutic sensitivities from baseline tumor and immune profiling. Further, intra-tumoral heterogeneity
can render distinct biopsies taken from the same patient tumor discordant.
In this revised IMAT proposal we capitalize on the clinical observation that upwards of 40% of GEA and 70%
of ovarian patients develop peritoneal carcinomatosis and ascites, a plentiful, heterogenous and
molecularly representative sample format that is easily accessible since routine drains occur during patient
care. However, in standard practice, such drains are discarded with little detailed evaluation or analysis - and
given highly variable tumor purities, bulk profiling is rarely informative.
To address these challenges, we have developed the first generation of AscitesPredict, a zero passage ‘ex
vivo tumor biosensor’ technology that uses single cell technologies to evaluate cell identities and therapeutic
sensitivities during a 5 day period in which viability is preserved. AscitesPredict utilizes high dimensional label-
free single cell image-based morphological profiling and machine learning applied to brightfield microscopy which
can be collected continuously. Thus far, we have developed AscitesPredict by profiling over 35 samples, made
initial assessments of technological reproducibility, and have optimized initial workflows.
In this revised proposal we take the next steps to harden the technology to prepare it for wider deployment in
research settings to support preclinical drug development and in clinical settings as a functional diagnostic. Our
goals will be achieved via two Specific Aims. First, we will evaluate real world technical and biological
performance characteristics. Second, we will demonstrate broader applicability of drug response
measurements by enabling the evaluation of new classes of therapeutic agents including those that impact
immune and stromal cells and improve the predictive accuracy of a wider diversity of cellular death
pathways beyond apoptosis to support preclinical therapeutic studies. At the conclusion of this project, the
technology will be poised for wider deployment across research settings and be sufficiently hardened to enable
the launch of a third phase of evaluation clinically as a companion diagnostic. Our focus both on major medical
centers and patients treated in the community will enable the widest, most equitable impact possible.
1

Public health relevance
PROJECT NARRATIVE: The proposed research is relevant to public health since long-term survival rates for patients with tumors of the stomach, esophagus or ovaries remain stubbornly low despite advances in genomics. This work, which takes an equitable approach towards inclusion of diverse samples from community hospitals, directly addresses this challenge based on the hypothesis that it is possible to use zero passage patient samples ex vivo on rapid timeframes to refine and validate associations between genotype and therapeutic dependency. Since this approach will enable both basic and translational cancer research across a range of populations it is centrally focused on the NCI’s mission to support research to reduce the morbidity and mortality of difficult-to-treat tumors such as advanced gastroesophageal adenocarcinoma and ovarian cancer. 1